This service is a MicroContract for DMPK Expert services for BPN, HEAL and Biologics. Incumbent is Gene Williams, Ph.D. POP: 07/01/2025 to 06/30/2026.

NINDS is seeking an executive (senior scientific)-level, industry-experienced drug discovery and development subject matter expert with a background in Drug Metabolism and Pharmacokinetics (DMPK) to provide technical support to the following Extramural Programs:

• The Blueprint Neurotherapeutics Network for Small Molecule (BPN-Small Molecule);
• NIH Blueprint Neurotherapeutics program (BPN);
• Other NIH neuroscience-focused drug discovery and development programs.

The NIH Blueprint for Neuroscience Research, a collaborative framework that includes the NIH Office of the Director and 12 NIH Institutes and Centers that support research on the nervous system, established the Blueprint Neurotherapeutics Network (BPN) as a pipeline between the typical endpoint of NIH-funded research and the beginning of industry drug development. The BPN provides neuroscience researchers with funding and access to a full range of industry-style drug development services and expertise. The program is intended for projects requiring medicinal chemistry optimization and Contract Research Organization (CRO) support through Phase I clinical testing.

Public health relevance
The National Institutes of Health (NIH) is the nation’s leading medical research agency and the primary Federal agency whose mission is to seek fundamental knowledge about the nature and behavior of living systems and the application of that knowledge to enhance health, lengthen life, and reduce illness and disability, conducting, supporting and making medical discoveries that improve people’s health and save lives. DMPK SME will provide executive (senior scientific)-level DMPK expertise and contribute feedback and guidance on projects to the NIH and to LDT members.